Radon Asthma Intervention Trial (ROME)

Project Summary/Abstract
Asthma is the most common chronic disease of childhood in the United States, causes significant morbidity, and
accounts for billions of dollars in health care utilization, despite aggressive measures to identify remediable
causes. Radon is the most important natural source of human exposure to ionizing radiation. Rn toxicity is due
to its decay products that emit alpha (α), beta (β), and gamma (γ) radiation that form ultrafine clusters that attach
to airborne particles rendering particulate matter (PM) radioactive. Radon sourced primarily from the adherence
of airborne radioactivity to particulate matter, is common in US homes due to the broad geologic presence of
radon in the earth's crust. Inhaled radon it associated radioactive PM deposits in the airways and alveolar regions
damaging nearby cells. Recent evidence from our lab and others has identified radon as a key contributor to
asthma and chronic obstructive pulmonary disease morbidity and mortality beyond the known carcinogen effects.
These adverse health effects are seen at levels below the current World Health Organization recommended
exposure thresholds for radon mitigation. We have collaborated for over 15 years to investigate environmental
hazards in schools and homes of children with chronic respiratory diseases. From these studies, we have
generated preliminary data that demonstrate: i) indoor Rn is associated with asthma symptoms and airway
inflammation in children and ii) it is well-established that radon mitigation systems significantly reduce radon by
90% and thereby reduce particle radioactivity. Although our data is promising, the impact of radon mitigation on
improving health outcomes can only be answered in a clinical trial. The results of our study could impact clinical
practice. Our overall hypothesis is that reduction of radon in homes will result in significant reduction of asthma
symptoms and inflammation in children with asthma. We propose a 48 week randomized, sham controlled,
radon mitigation intervention trial in 180 children with asthma who live in high and low radon geologic exposure
areas to 1) determine the effect of radon mitigation in the primary living space on asthma symptoms, primarily,
as well as lung function; and 2) determine whether radon mitigation will reduce established biomarkers of
inflammation, specifically airway FENO and established inflammatory biomarkers (IL4,5,13, 6, and C-Reactive
Protein (CRP)). This study is an unprecedented, high impact opportunity to test a personalized remediation
strategy for a ubiquitous but novel harmful respiratory exposure. Determining the benefit of radon interventions
offers a precise and personalized mitigation strategy to improve asthma morbidity. These findings will inform
public health policy regarding the risks of residential radon exposure in children with chronic health conditions
and thresholds for mitigation. It will allow us to identify health burdens resulting from real-life indoor exposures
and associated health effects among vulnerable children with asthma. If successful, this will provide guidance
on cost-effective, environmentally-friendly, and scalable technologies to improve indoor air quality to reduce
disease burden in an area of significant unmet need in children with chronic airway inflammation and asthma.

Public health relevance
PROJECT NARRATIVE Asthma is a disease that affects more than 12% of Americans under the age of 18 and environmental pollutants are known to cause symptoms and exacerbations. The goal of this project is to test a personalized radon intervention to improve asthma symptoms in children with asthma, with particular focus on reducing radon and associated particle radioactivity which is commonly present in US homes. This will provide guidance on a cost-effective, environmentally friendly, and scalable technology to improve indoor air quality to reduce disease burden.